IGF::OT::IGF Working Group: Measuring Core Variables in Adult Weight Loss Trials: Toward Optimizing Long-Term Obesity Treatment

Logistical support services for Measuring Core Variables in Adult Weight Loss Trials: Toward Optimizing Long-Term Obesity Treatment working group meeting.